Closed-loop rescue of sudden unexpected death in epilepsy by regulating dorsal raphe functions

PROJECT SUMMARY
Sudden unexpected death in epilepsy (SUDEP) is the primary cause of death in individuals with epilepsy,
representing a significant public health concern. Unfortunately, there are currently no methods to predict or
prevent SUDEP. In recent work, we demonstrated that ictal (i.e., during a seizure) local field potential
(LFP) suppression in the dorsal raphe nucleus (DRN) precedes seizure-induced sudden death in a mouse
model of SUDEP. In unpublished data, we can significantly reduce the SUDEP rate using closed-loop
electrical DRN stimulation upon detecting ictal DRN LFP suppression. Our preliminary data also point to
reduced ictal serotonergic (5-HT) neuronal activity and increased extracellular GABA levels in the DRN of
SUDEP model mice. Building on our compelling preliminary results, we propose to test whether closed-
loop stimulation of ictal DRN function can prevent SUDEP in two mouse models (Aim 1) and further refine
this therapeutic approach by elucidating the cellular (Aim 2) and synaptic (Aim 3) mechanisms of ictal DRN
function in regulating SUDEP. This proposal will test our data-driven central hypothesis that closed-loop
restoration of DRN neuronal activities prevents SUDEP by modulating 5-HT and GABAergic systems. This
hypothesis will be tested via the following specific aims in two SUDEP mouse models. In Aim 1, we will
leverage logistic regression and two newly developed machine-learning techniques to identify ictal events
that can predict the lethality of seizures. We will then test whether closed-loop ictal DRN electrical
stimulation can prevent SUDEP. In Aim 2, we will determine the dynamics of DRN5-HT and DRNGABA
neuronal activities (calcium imaging) during fatal seizures using simultaneous LFP-fiber photometry
recordings. We will subsequently assess their contribution to SUDEP by utilizing the closed-loop
optogenetic approach to selectively manipulate DRN5-HT and DRNGABA neuronal activity when fatal seizures
are detected. In Aim 3, we will delineate the specific contributions of GABAergic synaptic inputs to DRN by
inhibiting GABA release at DRN presynaptic terminals. Using parapinopsin (PPO) for presynaptic optogenetic
inhibition, we will target GABAergic inputs from each of the DRNGABA, the bed nucleus of the stria terminalis
(BNSTGABA), and central amygdala (CeAGABA), and subsequently assess their efficacy in rescuing SUDEP.
We have developed and validated the necessary tools for accomplishing these cohesive aims to expand
our knowledge of SUDEP and develop effective SUDEP prevention strategies toward clinical translation.

Public health relevance
PROJECT NARRATIVE Sudden unexpected death in epilepsy (SUDEP) is the leading cause of death in individuals with epilepsy, yet there are currently no methods for predicting or preventing it. This proposed study aims to develop a closed-loop rescue approach for SUDEP in mouse models. We will also delineate the cellular and synaptic mechanisms of the dorsal raphe nucleus in regulating SUDEP.